Determinants of response to cancer immunotherapy

PROJECT SUMMARY/ABSTRACT
While immunotherapy is transforming cancer treatment, the majority of patients do not achieve durable
responses. We have been studying response and resistance to different immune checkpoint inhibitors and are
now poised to propose mechanistic studies aimed at providing an understanding of the immune states and
pathways that mediate or inhibit response to immune checkpoint blockade. Using high-dimensional unbiased
single-cell RNA-seq (scRNAseq), we can identify both canonical and non-canonical immune effectors that can
mediate anti-tumor responses. We believe that non-canonical effectors such as cytotoxic CD4 T cells, which we
have recently described, are not effectively triggered by our current treatments. Using the same single-cell
approaches, we can identify both known and novel cell types in cancer patients that can mediate immune
suppression. In our first objective, we will determine whether combination immunotherapies that include drug(s)
targeting specific immunosuppressive cells can enhance the function of these cytotoxic CD4+ T cells. By
leveraging neoadjuvant clinical trials where patients receive immunotherapy prior to surgery, we will use single
cell genomics and proteomics to define whether these combinations can 1) target the desired
immunosuppressive mechanisms, and 2) enhance canonical and/or non-canonical effectors within the resected
tumors. We will also use this approach to determine whether we can map these specific cell states into the
circulating compartment. The second objective is based on a longstanding interest in our group to define the
dynamics of antigen-specific responses. Using single-cell T cell receptor sequencing, we can identify expanded
T cell clones as well as follow their localization. In addition to understanding how immunotherapy combinations
induce and modulate specific T cell clonotypes within the tumor, we can determine how immunotherapies can
induce functional plasticity to desired or undesired states. The third objective builds on our 20 year experience
using mouse models to dissect mechanisms underlying response or resistance to immunotherapy. We will
determine the functional significance of non-canonical immune effectors using depletion and knock-out
strategies. We will also determine how combination immunotherapies can elicit both effective or ineffective anti-
tumor immune responses, thereby guiding the design of future clinical trials. In conclusion, our proposal is based
on hypothesis-driven bench-to-bedside and bedside-to-bench mechanistic studies with the goal of advancing
cancer immunotherapy. With our deep expertise in this field, experience leading multi-disciplinary teams focused
on translational research, and a rich network of basic science and clinical collaborators; we are uniquely
positioned to succeed in the research plan outlined in this proposal.

Public health relevance
PROJECT NARRATIVE Despite the success of cancer immunotherapy as a therapeutic modality, the majority of cancer patients do not benefit from this treatment. Studies of the mechanisms of response and resistance to immune checkpoint inhibitors in the tumors and blood of treated cancer patients and in murine models will provide insights that will guide the design of new combinatorial therapies. By understanding the precise immune cells that can be induced to kill tumor cells, we ultimately seek to translate our findings to develop more effective immunotherapies tailored to drive these cells.